Mechanisms of islet compensation for β-cell mass deficiency in diabetes

ABSTRACT
Type 2 diabetes (T2D) is associated with insulin insufficiency. Increased glucagon secretion from pancreatic
α-cells exacerbates hyperglycemia by increasing endogenous glucose production. However, a model in which
hyperglucagonemia is completely maladaptive does not align well with recent observations indicating that α-cells
boost the function of neighboring β-cells. These studies, which identify an insulinotropic role of glucagon under
physiological conditions, raise the possibility that increased glucagon secretion mediates an adaptive response
to the loss of functional β-cell mass in T2D. Consistent with this model, recent human studies suggest that α-cell
signaling via β-cell G-protein coupled receptors (GPCRs) is accentuated in T2D—however these correlative
studies do not test causality. To investigate how the loss of functional β-cell mass impacts islet cell crosstalk and
glycemic control, we generated a novel strain of β-cell replication-deficient mice (hereafter, abbreviated ‘βRD’).
Studies performed in vivo, and in isolated islets, suggest that increased glucagon release from α-cells is essential
for the preservation of insulin secretion and organismal glycemia in βRD mice. Single-cell RNA sequencing
(scRNAseq) of βRD islet cells indicates α-cell intrinsic reprogramming of metabolism and hormone secretion.
Based on these findings, our central hypothesis is that α-cell hypersecretion is essential to preserve insulin
secretion in response to β-cell mass deficiency. Testable predictions of this model include: increased glucagon
secretion in βRD mice is insulinotropic; signaling through β-cell GLP1R and/or GCGR is essential for the
observed β-cell adaptations in βRD mice; and that similar mechanisms occur in human islets with reduced β-cell
mass. We will: (1) Determine the signaling mechanisms underlying β-cell compensation in a novel mouse model
of β-cell replication deficiency, (2) Determine mechanisms of α-cell compensation in β-cell mass-deficient mouse
islets, and finally, by transplanting human pseudoislets with controlled α:β ratios, we will test whether increased
α-cell signaling can compensate for β-cell mass deficiency in vivo. Completion of these aims will test the concept
of adaptive hyperglucagonemia in T2D. Whether or not this hypothesis proves correct, these studies will identify
islet mechanisms of functional compensation for β-cell mass deficiency, elucidate α-cell signals that functionally
rescue insulin secretion, and identify GPCR pathways for therapeutic targeting in diabetes.

Public health relevance
Narrative Over 400 million people suffer from type 2 diabetes, a disease associated with insulin insufficiency arising from the loss of β-cell mass and function. These studies will provide new insights into the mechanisms by which islets compensate for the loss of functional β-cell mass, by investigating the mechanistic underpinnings of increased glucagon secretion from α-cells and its effect on the neighboring β-cell. This work may lead to new therapeutic approaches to restore insulin secretion in patients with type 2 diabetes and related metabolic diseases.